Quantitative Ultrasound To Diagnose Nonalcoholic Fatty Liver Disease in Children.

SUMMARY
Our broad long-term objective is to improve the health of children with nonalcoholic fatty liver disease (NAFLD),
a condition characterized by accumulation of fat in liver cells, by developing and validating accurate, precise,
practical, and widely available tools to detect, measure, and monitor liver fat. Over 5 million American children
have NAFLD, placing them at risk for type 2 diabetes, cirrhosis, and premature death. Addressing this health
crisis is crucial for our nation. Clinical practice guidelines recommend screening for NAFLD in American children
aged 9 to 17 years with overweight or obesity because early diagnosis, prompt specialist referral, and NAFLD-
tailored management can improve outcomes. However, there is no accurate, precise, practical, and widely
available diagnostic tool to implement these guidelines, a major unmet need in pediatric NAFLD. Quantitative
ultrasound (QUS, US) holds promise to address this unmet need, but notable gaps in QUS technology persist:
Gap 1) unsatisfactory accuracy of current commercial QUS methods for estimating liver fat content in children;
Gap 2) availability of commercial QUS technology mainly on full-size (US) systems, primarily located within
radiology departments, limiting access for many children at risk NAFLD; and Gap 3) poor cross-vendor
reproducibility, which undermines utility. Our immediate goal is to address these gaps by developing advanced
QUS analysis models for use with full-size US or inexpensive POCUS systems in children at risk for NAFLD to
estimate liver fat fraction and classify presence/absence of fatty liver. The models will incorporate technical
innovations to improve QUS accuracy and efficiency. To develop and test these models, we propose a cross-
sectional accuracy and precision clinical study in 140 children (ages 9 to 17 years) suspected to have NAFLD,
who will undergo full-size US and POCUS exams with contemporaneous MRI-proton density fat fraction as
reference. Our three specific aims are: Aim 1. To improve accuracy of QUS on full-size US for liver fat
assessment in children. Aim 2. To translate QUS liver fat assessment in children to POCUS. Aim 3. To improve
cross-vendor reproducibility of QUS liver fat assessment in children. We hypothesize that our QUS models using
either full-size US or POCUS will estimate liver fat content more accurately than other US methods. We also
expect our models to classify presence/absence of fatty liver in children more accurately than other US methods.
Exploratory aims are to: a) explore associations between QUS and histology; b) explore effects of potential
confounders on accuracy and precision of QUS models; c) create a repository of US data, plasma, and digitized
histology for future research. Impact: Achieving our study aims will enable multi-center, multi-vendor trials, which
collectively have the potential to transform clinical practice and therapeutic discovery in children by enabling
widespread dissemination of reliable, practical, and generalizable diagnostic solutions for pediatric NAFLD.

Public health relevance
PROJECT NARRATIVE Nonalcoholic fatty liver disease (NAFLD) is a growing health concern that affects nearly 10% of all children and one in four children with obesity. The proposed research aims to validate the use of quantitative ultrasound (QUS) as a diagnostic tool for children at risk of NAFLD. By providing a better, safer, and more accessible method for diagnosing NAFLD in children, this study has the potential to transform clinical practices and contribute to public health initiatives focused on equitable healthcare for all children.